Proteomics

Abstract
The overarching goal of the Proteomics Core (Core 3) is to provide state-of-the-art, mass spectrometry-based-
proteomics and phosphoproteomics data and analyses in support of Projects 1-3. Genetic alterations in human
cancer have been systematically mapped by genomics landscape studies in the past decade, however, the direct
consequences of these alterations on the functional proteome are poorly understood. Deep scale, mass
spectrometry (MS)-based proteomic data when integrated with genomic data (`proteogenomics') have been
shown to improve specificity for identifying cancer-relevant pathways triggered by somatic DNA variants or DNA
copy number alterations (CNAs) compared to genomic characterization alone, and help to narrow target
selection for potential therapeutic intervention. Proteomics alone, especially with deep, quantitative profiling of
posttranslational modifications (PTM) provides information on signaling related to disease pathophysiology that
are largely opaque to genomics.
Core 3 will apply micro-scaled mass spectrometry-based proteomics technologies we have developed that utilize
highly multiplexed stable-isotope mass tagging (TMT 16-plex) for precise relative quantification of the proteome
and phosphoproteome of very small amounts with very deep coverage for the study of transformation of chronic
lymphocytic leukemia (CLL) to Richter's Syndrome (RS). The resulting proteomic data, including the critical
quantitative and site-specific modification information, will be integrated with personalized genomic data using
bioinformatics tools that have been integrated into the cloud-based pipeline PANOPLY. Multi-omics clustering
and analysis will be done to define the intrinsic structure of the integrated proteogenomes across baseline and
treated samples. We will extract proteogenomic features that drive the underlying cluster structure and will
perform pathway-level analysis to further characterize each cluster in CLL and RS samples. Copy number to
mRNA, protein, and phosphoprotein correlations will be done to determine cis- and trans-regulated genes.
Pathways and molecular mechanisms underlying treatment response in patient and mouse models will be
explored using single sample Gene Set Enrichment Analysis (ssGSEA), and PTM Signature Enrichment Analysis
(PTM-SEA) will be used to perform pathway analysis on phosphorylation data generated.
To enable more rapid and specific analyses of proteins and phosphopeptides targets of interest emerging from
the discovery experiments, the proteomics core will develop high sensitivity targeted MS assays, to be utilized
in Projects 1-3. Assays developed will use stable isotope-labeled standards for unambiguous identification and
quantification and applied to human biospecimens and preclinical samples in native and drug-perturbed states.

Public health relevance
Narrative The overarching goal of the Proteomics Core (Core 3) is to provide state-of-the-art, mass spectrometry-based- proteomics and phosphoproteomics data and analyses in support of Projects 1-3; proteomics data will help to identify cancer-relevant pathways triggered by somatic DNA variants or DNA copy number alterations (CNAs) and help to narrow target selection for potential therapeutic intervention of Richter's syndrome and related cancers. The resulting proteomic data, including the critical quantitative and site-specific modification information, will be computationally analyzed and integrated with personalized genomic data using bioinformatics tools integrated into the cloud-based pipeline PANOPLY. To enable more rapid and specific analyses of proteins and phosphopeptides targets of interest emerging from the discovery experiments, the proteomics core will develop high sensitivity targeted MS assays and apply these to analyze human biospecimens and preclinical samples in native and drug-perturbed states.